Multicomponent intervention to improve delirium and sleep-wake rhythms in older ICU patients

PROJECT SUMMARY
Candidate: Biren Kamdar, MD, MBA, MHS is an Associate Professor of Medicine and intensive care unit (ICU)
physician with a career goal of making novel discoveries regarding delirium and sleep in the ICU setting, par-
ticularly in the ever-expanding population of older critically ill patients. Bringing a strong research background,
including prior leadership of an NIH-supported ICU sleep promoting effort, Dr. Kamdar’s career goal is to gain
the skills necessary to independently design, implement, evaluate and sustain multi-site interventions to im-
prove delirium and sleep-wake rhythms in older ICU patients. Research Project: Older patients in the ICU
are predisposed to delirium and misaligned sleep-wake rhythms, placing them at high risk for adverse out-
comes following ICU discharge. As older adults comprise the majority of ICU patients and a rapidly expanding
proportion of the ICU survivor population, ICU-based interventions are needed to focus on this particularly vul-
nerable population. With the support of a strong mentorship and interdisciplinary stakeholder team, the parent
K76 proposal involves implementation and testing of a multicomponent intervention in two academic ICUs. To
reduce delirium and improve nighttime sleep quality in older ICU patients, the parent proposal pairs compo-
nents of Dr. Kamdar’s prior nighttime-focused efforts with daytime interventions. To enhance intervention im-
plementation, Dr. Kamdar’s team developed a video-based digital “ICU Delirium Playbook,” which includes
instructions for bedside providers regarding delivery of nighttime and daytime interventions. To extend this
effort further, Dr. Kamdar’s team partnered with diversity-focused experts to develop an “ICU Delirium Play-
book: Spanish Edition.” Support from this Diversity, Equity, Inclusion and Accessibility (DEIA) supplement will
help extend the parent K76 award to include outcomes data collection (e.g., actigraphy and delirium) in primari-
ly Spanish-speaking patients, and bolster mentoring activities for Dr. Kamdar’s diverse group of trainees, in-
cluding those from underrepresented and disadvantaged backgrounds. Career Development: Dr. Kamdar’s
career development plan includes mentored activities to develop expertise in (a) sleep-wake rhythms and delir-
ium and aging; (b) advanced actigraphy methods; (c) intervention development; and (d) implementation sci-
ence. The parent K76 award has provided Dr. Kamdar with a foundation for an independent research career
and leadership of large multi-site ICU interventions. Dr. Kamdar has mentored ~50 trainees over the past 13
years, including individuals from backgrounds underrepresented in biomedical research, and undergraduates
who lack direct access to clinical opportunities and research mentorship. This DEIA supplement will support
Dr. Kamdar’s mentoring efforts by providing stipends for trainees and by adding DEIA-focused research sup-
port to guide the team in delivering interventions to more diverse ICU populations.

Public health relevance
PROJECT NARRATIVE Older adults (≥65 years old) now comprise the majority of patients in intensive care units (ICUs). In the ICU setting, these older patients frequently experience delirium and misaligned sleep-wake rhythms, placing them at high risk of poor outcomes after ICU discharge. This proposal involves enrollment of an interdisciplinary team to implement a multicomponent intervention in two academic ICUs, with the goal of improving delirium and sleep-wake rhythms (as measured using wrist actigraphy) in a diverse population of older ICU patients.